Developmental Trajectories to Stuttering Persistence and Recovery

Summary
Stuttering or childhood onset fluency disorder, affects 5-8% of preschool-aged children. Although many
children’s stuttering resolves within 12-24 months of onset, those who continue to stutter beyond age 7 are at
significant risk for chronic stuttering. For children who persist, speaking often becomes a lifelong struggle. The
negative consequences for academic/vocational achievement and psychosocial development suffered by
many of these children are substantial and long lasting.
Prior studies in preschool children who stutter (CWS) have identified demographic, behavioral, and
physiological factors associated with stuttering persistence by comparing performance across groups of
preschool children. Yet, we do not know how a child’s unique developmental pathway leads them to recover or
persist in stuttering. This limits our ability to predict a child’s risk of developing persistent (chronic) stuttering
reliably and to develop efficacious prevention and treatment strategies.
This project shifts experimental focus, for the first time, to the individual child, providing a dynamic
account of how neurological, behavioral, and experiential factors unfold over time and contribute to different
stuttering outcomes. We achieve this through our comprehensive, longitudinal design and structural equation
modeling framework, in which we map the developmental trajectories of critical factors implicated in stuttering.
In our approach, we use a novel neuroimaging technique, functional near-infrared spectroscopy (fNIRS), that
allows us to record brain activity concurrent with continuous speech production, a distinct advantage of this
technique. We will assess whether neural markers derived from fNIRS recordings identified in our research
with older CWS can distinguish preschool children at risk for persistence, thereby helping to establish a neural
basis for stuttering persistence and recovery. We will also assess whether atypical coupling between
sympathetic nervous system activity and speech output, detected in cross-sectional studies, represents a risk
factor for chronic stuttering. Finally, stuttering leaves a lasting imprint on children who persist. Ample evidence
shows that older children and adults are more likely to harbor negative emotions about their speech and/or
develop communication anxiety. We lack a continuous picture, however, of how these issues develop in young
children whose awareness of stuttering is emerging. We will examine how behavioral, emotional, and
experiential factors unfold over time and explore their roles in stuttering persistence or recovery and in the
development of negative communication attitudes.
This project will bring new, comprehensive insights into why stuttering persists in individual children,
and, in parallel, help better prioritize therapy resources, identify etiological targets for prevention and
intervention, and accelerate the development of new treatments.

Public health relevance
Project Narrative Stuttering affects 70 million people worldwide and has lifelong adverse consequences. This project examines the mechanisms underlying the development of stuttering in individual preschool children. We use a comprehensive, multilevel approach to map the development of neurological, behavioral, and experiential factors to learn how these factors unfold over time and contribute to different stuttering outcomes—persistence or recovery. This proposal is consistent with the mission of NIH in that scientific discoveries from our research will improve understanding of how stuttering develops in individual children, leading to advances in diagnostic and intervention approaches.